Linking Social-Behavior Contextual Factors and Allostatic Load to Chronic Diseases in Diverse Asian Americans: A Socioecological Approach to Advancing Precision Medicine and Health Equity

PROJECT SUMMARY/ABSTRACT
Asian Americans (AA) are the fastest growing and most diverse racial/ethnic group in the US, recording a 81%
growth from 2000 to 2019. Counter to the “model minority myth,” the AA has broad variations in income,
education, and nativity status by subgroups. AAs also have unique and unequal patterns of health behaviors,
cardiometabolic conditions, endocrine dysfunction, cancer, and mental illness. We must also acknowledge the
lived experiences of the diverse AA populations: historical trauma, racism, re-adjusting to life in a new country
as immigrants or refugees, and navigating unfamiliar healthcare systems. Unfortunately, lack of disaggregated
data limited our understanding of allostatic load (AL) in the diverse AA populations. Therefore, we propose a
paradigm shift towards understanding the cumulative toll of chronic stress through the concept of allostatic load,
its behavioral and social-contextual correlates, and how AL manifests as chronic diseases among AAs, by Asian
ethnic subgroups. AL is a complex clinical construct that offers a unique lens into the cumulative toll of stress
and how it manifests as physiological and psychological dysfunctions (i.e. chronic conditions). Analyses of
disaggregate data are needed to uncover specific risk patterns by AA subgroups and reduce health disparities
through tailored interventions. The All of Us (AoU) Research Program provides unprecedented opportunities for
us to close the gaps in literature and advance scientific knowledge. Leveraging the diverse and inclusive AA
subsample (N = 12,408), we seek to model AL as a complex system to capture a more comprehensive extent of
health risk in AA subgroups, identify high-risk groups, and explore how AL as various chronic illnesses. All
analyses will be conducted in aggregate AA sample first and then in 4 ethnic/regional subgroups: East Asian
(Chinese, Japanese, Korean), Southeast Asian (Vietnamese, Cambodian, Hmong), South Asian (Indian,
Pakistan), and Filipino. The specific aims are as follows: Aim 1: To examine the physiological risk profiles and
how sociodemographic, behavioral, social-contextual, and acculturation-related factors are associated with AL
in aggregated Asian American (Aim 1a) and separate AA subgroups (East Asian, Southeast Asian, South Asian,
and Filipino Americans) (Aim 1b). Aim 2: To explore subgroup disparities in stress manifestations by examining
how AL is associated with multiple chronic conditions in aggregated (Aim 2a) and separate AA subgroups (East,
Southeast, South, and Filipino Americans) (Aim 2b). The proposed analyses will help identify clinically and socio-
demographically important subgroups of AAs at high risk for physiological and psychological dysregulation. With
dissemination activities jointly led by researchers and clinical/community stakeholders, this study will ultimately
guide future lifestyle and behavioral interventions to improve resilience in AAs and provide clinical implications
for a more personalized medicine to stress mitigation and chronic disease prevention.

Public health relevance
PROJECT NARRATIVE Allostatic load (AL) is a complex clinical construct that offers a unique window into the cumulative toll of stress and how it manifests as physiological and psychological dysfunctions. This proposed study will leverage the Asian American (AA) subsample from the All of Us Research Program to understand the cumulative toll of chronic stress through the concept of AL, its behavioral and social-contextual correlates, and how AL manifests as chronic diseases among AAs, in aggregate and by four regional/ethnic subgroups (East Asian, Southeast Asian, South Asian, and Filipino Americans). Through dissemination activities jointly led by the researchers and community/clinical stakeholders, we expect the findings of this study will guide future lifestyle and behavioral interventions to improve resilience and provide clinical implications for personalized medicine to mitigate stress and prevent chronic diseases in understudied AAs.